Subproject 4: Role of Pumps in Resistance, Physiology, and Infection

Summary
The longterm goals of the project are to identify the full array of efflux pumps of Staphylococcus
aureus and Enterococcus spp that contribute to multiple antimicrobial resistance and to elucidate
the determinants of their expression, their role in microbial physiology and their effect on bacterial
response to antimicrobials in infection. The work will focus on a structural and functional analysis
of the Tet38 efflux pump that enables multidrug resistance, survival in abscesses, and invasion
of epithelial cells, the potential contribution of multiple pumps to persister subpopulations in the
presence of antimicrobials, expanding the understanding of efflux resistance in enterococci, and
evaluating collaboratively novel novel antimicrobial compounds for effects of efflux, tissue
tolerability, and in vivo efficacy. There are four specific aims: 1) assess the structural determinants
of the S. aureus Tet38 efflux pump in resistance, physiology, and pathogenesis and determine
the mechanism of its diverse effects on cellular physiology; 2) explore the conditions promoting
and heterogeneity of S. aureus efflux pump expression in single-cell groups; 3) evaluate the role
of effux pumps in resistance in enterococci; and 4) evaluate the effect of S. aureus efflux pumps
on novel compounds from collaborating projects. The work will utilize genetic manipulation, allelic
exchange, and expression vectors in S. aureus and E. faecalis, measurements of gene/protein
expression with fluorescent reporters, and established murine models of infection (subcutaneous
abscess, intestinal colonization) utilizing a genomically defined strains. The overall goal of the
program project is to take a well‐integrated, multi‐disciplinary approach to understanding antibiotic
resistance development and efflux within cellular physiology combined with the search for
compounds that compromise resistant pathogens by inhibiting novel targets and pathways. This
project will add to understanding of resistance mechanisms related to multidrug efflux pumps and
provide strains for testing the effect of such pumps on novel compounds active against new
targets and pathways. It will also utilize a mammalian model of infection to screen new compound
tolerability and in vivo activity.

Public health relevance
Narrative Multidrug resistance in S. aureus is an increasing clinical and public health problem that requires additional understanding of its mechanisms of development and spread and establishment of novel targets that may be exploited to develop new effective therapies.